Diabetes Progression with Metabolomic Profiling in Starr County Mexican Americans

Summary/Abstract
Type 2 diabetes spans a broad and complex phenotypic spectrum, but its metabolic changes and progression
start early, even years prior to diagnosis. Interventions have considerable preventive promise in these early
stages. The challenge, however, is identifying the earliest changes of disease development and what is driving
those changes. Metabolomic data provide crucial information to understand early metabolic changes and
different etiologies of type 2 diabetes, especially with the longitudinal multi-omics setup proposed in this. We
have been studying complex chronic diseases among Mexican Americans in Starr County, Texas to identify
genetic and other risk factors leading to their disproportionate burden of disease. The main goal of this project
is to understand underlying biological processes and pathways involved in worsening glycemic profiles and the
development of type 2 diabetes. This study will analyze metabolomic profiles of 600 individuals at six time points,
300 with prediabetes and 300 with normal glycemia, in conjunction with separately funded diabetes prevention
and microbiome studies. Genomic data on nearly all samples includes whole exome sequencing and GWAS
genotyping with whole genome imputation. By adding several thousand metabolites to our extensive prospective
longitudinal phenotypic and microbiome resources, we will identify metabolites that are associated with disease
progression and are differentially associated with subtypes of prediabetes. We also have significant advantages
to reveal causal relationship by longitudinal correlation analysis for lagged effects and by Mendelian
randomization. Our pilot data already identified metabolomic signatures that are sensitive indicators of
prediabetes status and its subtypes. We will perform integrative analyses of the proposed multi-omics dataset to
understand pathways and their genomic underpinnings leading to prediabetes, diabetes, and progression with
these specific aims: 1) Identify metabolites and pathways that are most indicative of worsening glycemia by
analysis of longitudinal metabolomic profiles of individuals over the three years, 2) Identify metabolites and
pathways that are most indicative of prevalent prediabetes status, 3) Identify metabolites that are highly
associated with microbiota by analyzing temporal patterns of microbiomic and metabolomic profiles to
understand their integrative role in the development and biology of prediabetes and diabetes, 4) Identify currently
unnamed metabolites associated with prediabetes to construct a candidate set of unknown metabolites and
verify the identity of unknown metabolites with computational analysis and experimental validation, and 5)
(exploratory) Analyze genomic data to identify genes and variants associated with diabetes-related metabolites.
With this project, we will bring together metabolomic, microbiomic and genomic profiles to identify changes in
metabolic profiles of prediabetes in a longitudinal design. This will lead to understanding of the early progression
of diabetes that will be exploitable for prevention and enhanced palliative approaches.

Public health relevance
Narrative/Public Health Relevance Diabetes is a complex trait and understanding its progression at the early stages (prediabetes) and their subtypes is important to understand biology of diabetes. Longitudinal metabolomic data aligned with microbiomic and genomic profiling will be a unique resource that provides insights affecting large population. This project will provide clues for early interventions before progression of diabetes.